Perceptual Coding and Modulation of Odor Objects in the Human Brain

DESCRIPTION (provided by applicant): A central goal of neuroscience is to clarify how the brain transforms sensory inputs into perceptual representations. Curiously, even though odor stimuli are at the heart of goal-directed behavior, including feeding, mating, and maternal bonding (for both human and non-human species), very little is known about the neural transformations that create olfactory percepts out of airborne molecules. Because most odors are complex mixtures of different molecules, an important challenge of olfactory systems is to re-assemble these parts into coherent perceptual wholes, or objects, that are perceptually anchored to their original sources in the environment. Understanding how the human brain encodes, discriminates, and categorizes olfactory objects is a key research focus in our lab. An advantage to studying humans is that they can talk and provide ratings of their sensory experiences, offering a highly tractable way to relate brain activity patterns directly to perception. In work proposed here, we will leverage our current strengths in olfactory psychophysics, functional magnetic resonance imaging (fMRI), and pattern-based imaging analysis with new methodological, experimental, and computational approaches to dissect the components of odor perceptual processing at the behavioral and neural levels. By effectively deconstructing either the odor stimulus or the olfactory system, we will be able to gain unique insights into the functional organization of odor object coding and recognition. Specific studies will explore where conscious perception of an odor arises in the human brain, how higher- order regions contribute to perceptual coding and categorization, and whether the brain has access to individual elements of a behaviorally salient food odor. Complementary studies will investigate the role of familiarity, reward learning, and levels of prior belief on the emergence and modulation of odor object patterns and connectivity in olfactory and non-olfactory brain areas. Together these experiments will bring novel understanding of how the human brain overcomes the challenges of recognizing odor objects, and will highlight the key regions that are instrumental in supporting odor perception. In addition, our findings should usefully inform the human neurobiology of the other sensory systems, and should contribute valuable basic information that could help guide development of future diagnostic strategies in patients with Alzheimer's disease and Parkinson's disease, which are associated with olfactory perceptual deficits in their earliest stages.

Public health relevance
PUBLIC HEALTH RELEVANCE: In combining cutting-edge neuroimaging techniques with olfactory psychophysical approaches in healthy human subjects, the proposed research will generate new insights into odor object recognition and coding in the human olfactory system, and may help inform the neurobiology of object processing in other sensory systems. Furthermore, given that abnormalities in the sense of smell often emerge as an early or premonitory sign in many different neurodegenerative syndromes, including Alzheimer's disease and Parkinson's disease, the work proposed here may help lead to the development of new imaging biomarkers for pre-clinical diagnosis of these disorders.